Ribosomal RNA modification in nucleoli and disease

ABSTRACT
Nucleoli produce 1-10 million ribosomes per cell. They are membraneless organelles in the nu-
cleus formed by liquid-liquid phase separation (LLPS). Dysregulation of ribosome synthesis causes
many inherited and somatic diseases. How phase separation contributes to ribosome biogenesis is un-
known. We focus on the dense fibrillar component (DFC) of the nucleolus. Nascent pre-ribosomal
RNAs (rRNAs) extend into the DFC as they are modified, folded, and processed with the aid of hun-
dreds of biogenesis factors and modifying small nucleolar ribonucleoproteins (snoRNPs). How these
processes coalesce to produce properly processed and folded rRNA that is fully modified at some 200
nucleotides is a mystery. To elucidate this complex but efficient process, we need to understand how
the DFC is formed, how it enables cotranscriptional RNA modification, and how it is impacted by inher-
ited disease. Having identified the snoRNP chaperone Nopp140 and the pseudouridine synthase
NAP57 (aka dyskerin and Cbf5) while studying snoRNPs for over 30 years, puts us in a favorable posi-
tion to successfully address these questions in the following three aims. One, determine how the dense
fibrillar component of the nucleolus forms, two, identify the mechanism of cotranscriptional RNA modifi-
cation, and three, define the impact of dyskeratosis congenita. We show in preliminary data that
Nopp140 concentrates snoRNPs through interaction with their intrinsically disordered domains. We
identify a novel disordered C-terminal domain in an RNA polymerase I subunit PAF49 that also binds
Nopp140. Based on these data we hypothesize that snoRNPs concentrate at pol I via Nopp140 to co-
transcriptionally modify rRNA. This process is supported by LLPS, which forms the DFC. Additionally,
missense mutations in NAP57 and other RNP components impact both processes, LLPS and rRNA
modification. In this application, we will test these hypotheses. Understanding biogenesis and function
of the DFC, the link between snoRNP abundance and rRNA modification, and the impact of inherited
disease provides a basis for therapeutic intervention.

Public health relevance
PROJECT NARRATIVE The nucleolus is the ribosome factory of the cell. Ribosomes in turn are the cellular machines that synthesize all proteins. The most important component and backbone of ribosomes is its RNAs. Ribosomal RNAs are heavily modified by small RNA-protein complexes to properly exert their func- tions. This process occurs in one of three recognizable subcompartments of the nucleolus, the dense fibrillar component (DFC), which we propose to be formed by the modification activity. One of the two major families of the small RNA-protein complexes are impaired in dyskeratosis congenita. Patients with the bone marrow failure syndrome dyskeratosis congenita (DC) fail to produce suf- ficient blood cells to carry oxygen and fight infections. Most frequently DC is caused by mutations in proteins that associate with many different small noncoding RNAs that are required for a vast spectrum of cellular functions. Although one of these functions has been shown to be impaired in DC patients, it is not known if and to what extent other functions associated with these RNA–protein complexes are affected. For example, we will investigate if and how these RNA–protein complexes affect the nuclear organelles where they are found, when they are mutated in DC. This proposal aims to answer these questions and to solve the mystery that underlies the nucleolus and DC. The experiments will charac- terize the fine structure of the nucleolus and identify new avenues of treatment for patients with DC and possibly with other bone marrow failure syndromes.